Multilevel Contributors to Cognitive and Physical Function Decline in Older African Americans

PROJECT ABSTRACT Maintaining good cognitive and physical health are among the highest priorities for older adults. However, older African Americans are disproportionately impacted by age-related dementia and physical impairments. Black-white racial disparities in cognitive and physical function have often been attributed to differences in chronic disease rates and socioeconomic factors, but disparities persist independently of these factors. Health disparities arise due to a complex interplay of social determinants across multiple levels but few studies have focused on the combined impact of these multilevel factors. This proposal aims to develop an ecological model of age-related decline using latent class analyses integrating social determinants of health and culturally- relevant predictors of decline among older African Americans. Through this approach we will focus on the combined impact of these multilevel factors, incorporating the community environment, interpersonal relationships, and individual factors. As the older U.S. population grows, it is also becoming more diverse; over the next four decades the older African American population in the US is expected to grow from 4 million to 12 million. Understanding drivers of age-related outcomes as well as identifying culturally-relevant predictors of impairments among vulnerable populations is crucial to ensure that all people have the opportunity to age healthily. Through the first aim of this study, we will link community-level data from a variety of sources via geocoded addresses to data from the Minority Aging Research Study, an ongoing longitudinal study of risk factors for cognitive decline in community-dwelling African Americans, age 65 years and older who enrolled without known dementia. We will then identify latent classes of community-level characteristics and compare interpersonal and individual factors among such classes. In our second aim, we will assess the cross-sectional and longitudinal associations among multilevel exposures (from Aim 1) and cognitive and physical function. In our third aim, we will estimate the role of multilevel exposures on incident mild cognitive impairment, Alzheimer’s disease, and mobility disability. Ultimately, results will contribute to efforts aimed at determining intervention targets to prevent and treat across several domains of functioning. These results could also be extended and tested within other racial/ethnic groups to better understand unique factors impacting aging among other minorities.

Public health relevance
PROJECT NARRATIVE Older African Americans are disproportionately impacted by impairments in cognitive and physical function as they age. This project will examine the combined impact of multilevel social determinants of health—including community environment, interpersonal relationships, and individual factors—on cognitive and physical function in older African Americans.